West African Emerging Infectious Disease Research Center (WA-EIDRC)

Project Summary/Abstract:
Despite bearing a high burden of infectious diseases, Sierra Leone lacks a suitable system for
surveillance and outbreak response to emerging and existing pathogens. Through additional
support and funding, WARN-ID will be able to not only implement a high-throughput, multi-
analyte diagnostic testing platform as part of a comprehensive national surveillance system, but
also build local capacity for continued testing during outbreaks of SARS-CoV-2, its variants,
and other diseases like Lassa fever, Ebola, and malaria, which is the leading cause of death
and illness in Sierra Leone. The data that is generated from mCARMEN will be used to obtain
clinical validation and regulatory approval from the Pharmacy Board of Sierra Leone, as well as
inform future scale-up and integration into data visualization platforms beyond the scope of this
award. Further, developing the appropriate infrastructure to respond to COVID-19 and other
pathogenic threats will impact the country’s future ability to identify and respond to potential
outbreaks, by helping to lay the groundwork for a robust, sustainable public health
infrastructure able to detect emerging and reemerging pathogens and their variants.

Public health relevance
Project Narrative To address the urgent need for enhanced surveillance of SARS-CoV-2 and other infectious disease threats in Sierra Leone, we propose to pilot a key tenet of a comprehensive surveillance system in Sierra Leone, namely high-throughput, multi-analyte diagnostic testing, with our CRISPR-Cas13 platform for identifying pathogens and their variants, mCARMEN (microfluidic Combinatorial Arrayed Reactions for Multiplexed Evaluation of Nucleic Acids). The pilot site we have selected is Kenema Government Hospital (KGH), our existing WARN-ID site in the country. To this end, we will target four core aims including: (1) support the procurement and deployment of mCARMEN equipment and reagents at KGH for respiratory virus and SARS- CoV-2 variant identification, train KGH staff in its use, and generate data on 1,080 specimens from patients with respiratory illness; (2) prepare and submit an application to the Pharmacy Board of Sierra Leone for regulatory approval of mCARMEN for diagnostic use; (3) support the procurement and transfer of mCARMEN reagents at KGH for multi-pathogen identification and surveillance based on our West African febrile illness panel, and via KGH staff, generate data on 540 specimens from patients with febrile illness; and (4) prepare plans for future scale-up and data integration beyond the scope of this award.